Unraveling the tolerogenic potential of lymph node fibroblastic reticular networks in autoimmune diabetes

Project Summary:
Impaired central and peripheral tolerance cause type-1 diabetes (T1D); b-cell antigen-reactive T cells escape
negative selection in the thymus and regulation/deletion in lymph nodes. The role of professional antigen-
presenting cells and regulatory T cells in maintaining peripheral tolerance has been demonstrated and is
currently being evaluated for therapy of autoimmune diseases, including T1D. Conversely, non-professional
antigen-presenting cells like lymph node stromal cells are more stable tolerogenic cells but their potential for
therapeutic tolerance induction in T1D has not been tested yet.
Fibroblastic reticular cells (FRCs) are a subtype of lymph node stromal cells that support and remodel the lymph
node and the integrity of FRC reticula is critical for adaptive immunity. In transgenic mice, expression and
presentation of model antigens by FRCs to specific T cells induced their proliferation followed by deletion and
absence of MHC-II on lymph node stromal cells was associated with progressive development of autoimmunity.
Thus, FRC engineering for peripheral overexpression of tissue-specific antigens, including those not expressed
in the thymus, may be exploited for tolerance induction in the therapeutic treatment of autoimmunity. We showed
that expression of insulin, a major b-cell antigen, the relative FRC frequency and the FRC reticular remodeling
properties are decreased in T1D. Thus, to exploit the capability of FRCs to promote antigen-specific tolerance
for therapeutic treatment of T1D, FRCs need to be engineered to (i) increase their frequency by therapeutic
transplantation and (ii) overexpress disease-relevant antigens.
We recently developed genetic engineering approaches to overexpress T1D-relevant antigens, including hybrid
peptides, in FRCs and tissue engineering approaches to fabricate three-dimensional FRC reticula that
recapitulate FRC organization in the lymph node paracortex. Engineered FRC reticula overexpressing b-cell
antigens and lacking expression of costimulatory molecules engraft in mice to recruit antigen-specific T cells and
in vitro, engineered FRCs promote engagement of specific T cells, anergy, and regulatory T cell expansion,
which could promote antigen-specific tolerance in vivo. Thus, in aim 1.1, we will test the therapeutic application
of our engineered FRC reticula for tolerance induction and mechanisms in vitro and in vivo in a murine T1D
model with selected disease-relevant antigens. For clinical translation, in aim 1.2, we will evaluate whether
reticula engineered with b-cell antigen-expressing FRCs from human lymph nodes can engage human T cells
engineered for antigen specificity, which is important for clinical translation of our approach. Peripheral
expression and presentation of tissue-specific antigens by lymph node stromal cells to autoreactive T cells
escaping thymic deletion in lymph nodes could contribute to peripheral tolerance. In aim 2, we will test the
contribution of b-cell antigen expression and presentation by lymph node FRCs on tolerization of b-cell antigen
autoreactive CD8 T cells in a mouse model of T1D.

Public health relevance
Project narrative Defects in the regulation of immune tolerance can lead to autoimmune diseases, wherein uncontrolled reactivity to self-antigens leads to tissue damage, loss of function and diseases affecting multiple organs. Autoimmune diseases, such as Type-1 diabetes, cause a major burden to our society, and novel approaches that safely and specifically regulate the responsible immune cells to prevent and treat autoimmune diseases are lacking. This work will test new therapies for autoimmune diseases that involve engineered stromal cells for tolerance induction and will improve our understanding of lymph nodes as sites of immune tolerance induction.